The role of adipocyte-drive inflammation and leptin pathway in pulmonary viral infections caused by SARS-CoV-2 and influenza A viruses

SUMMARY
The “obesity pandemic” is a major global public health issue that affects more than 40% of the US population
and is tightly interrelated with type 2 diabetes mellitus (T2DM). Affected people are at least 3 times more likely
to develop critical and life-threatening respiratory viral (COVID-19 or influenza) infections. A large proportion of
the current and future human population is and will be at very high risk of severely suffering from these infections.
There is an indispensable need to study the underpinning mechanisms that drive increased susceptibility in
obese and diabetic subjects. The long-term goal is to elucidate the biological mechanisms by which metabolic
diseases influence the pathogenicity of viral respiratory infections. The overall objective of this proposal is to
determine the effects of dysfunctional adipocytes and the leptin pathway in shaping pulmonary innate responses
to respiratory viral infections. Our central hypothesis is that adipocyte secreted factors and impaired leptin
signaling alter homeostatic pulmonary host responses and enhance airway/alveolar epithelial permissiveness to
respiratory coronaviruses and Influenza virus A infections, with consequently increased lung injury associated in
part with higher viral replication. The rationale for this project is that the dissection of such responses is likely to
yield a strong framework whereby new therapeutic approaches targeting the leptin pathway can be developed
to ameliorate the impact of these infections in at-risk patients. The central hypothesis will be tested by pursuing
two specific aims: 1) investigate the influence of healthy and dysfunctional adipocytes and leptin signaling in
bronchial and alveolar air-liquid interface cultures following viral infection; and 2) investigate the contributions of
leptin signaling on pulmonary innate responses and its effects on clinical outcome, viral replication and lung
injury following in vivo Influenza A and SARS-CoV-2 infections. Under the first aim, human airway and alveolar
cultures on an air-liquid interface will be exposed to conditioned media derived from healthy and dysfunctional
human adipocytes and probed with siRNAs to dissect different components of the leptin pathway. For the second
aim, leptin receptor-STAT3 signaling-deficient, leptin receptor-SOCS3 signaling-deficient, and leptin receptor-
deficient mice will be employed to mechanistically understand the role of the leptin pathway in in vivo pulmonary
responses to SARS-CoV-2 and influenza virus A. The proposed research is innovative as it combines in vitro
and in vivo tools to mechanistically probe the leptin signaling pathway and understand its role in pulmonary
responses to viral infections, a substantive deviation from what is currently known. The proposed research is
significant as unravelling the precise role of the leptin signaling pathway during respiratory viral infection will
allow the identification of host pathway intervention points for precise intervention strategies to combat these
infections in at-risk obese and T2DM patients.